Administrative Core (AC)

The goal of this Administrative Core (AC) is to create the Louisville Clinical and Translational Research Center
(LCTRC) that provides a programmatic approach to C&T research that expands and fully integrates efforts and
connects them directly with existing IDeA COBREs and the INBRE programs at UofL. The AC will lead and
manage the cores supporting a single point of access for C&T research for UofL students, faculty, and
community members.
The AC will provide governance, needs assessment, evaluation, and ensure the cores work together
cohesively and in a coordinated manner through the following Specific Aims:
Specific Aim 1: Create a formal management and governance structure.
Specific Aim 2: Administer resources to increase clinical trial capacity and capabilities.
Specific Aim 3: Increase LCTRC and UofL IDeA COBREs and INBRE interaction and synergy.
Specific Aim 4: Create and optimize a Tracking and Evaluation program.
Impact. Achieving these aims will create a flexible and accountable management structure for increased C&T
research; enlarge the C&T research infrastructure, and add novel capabilities that will allow us to perform more
C&T investigations in the urban and rural populations. The LCTRC will serve as a single point of contact for
C&T research infrastructure, training, funding, and community engagement, which will ultimately lead to novel
therapeutics, decreased health disparities, and improved public health.